Omic and Multidimensional Spatial Atlas of Metastatic Breast Cancer

PROJECT ABSTRACT
We will continue development of our Omic and Multidimensional Spatial (OMS) Atlas that enables discovery of
mechanisms of resistance that arise in individual patients with metastatic breast cancer during treatment with
current generation targeted therapeutic combinations and immune checkpoint inhibitors. The OMS Atlas is
motivated by the fact that these treatments typically are only transiently effective in the metastatic setting.
Possible resistance mechanisms may be intrinsic to the tumor cells or derive from the diverse microenvironments
in which the tumor cells live. The OMS Atlas focuses on elucidating these resistance mechanisms in two current
generation clinical scenarios: (a) hormone-receptor positive breast cancer (HRBC) undergoing treatment with a
CDK4/6 inhibitor in combination with endocrine therapy, and (b) triple negative breast cancer (TNBC) undergoing
treatment with a PARP inhibitor and an immunomodulatory agent. We are accomplishing this through work via
four coordinated units. A Biospecimen Unit is prospectively collecting and distributing longitudinal clinical
information, blood, and biopsies from 30 cases across the two metastatic breast cancer cohorts. A
Characterization Unit is analyzing (a) OCT frozen specimens using single-cell DNA-seq and single-cell ATAC-
seq to elucidate spatially defined genomic changes and chromatin accessibility in single cells, (b) formalin fixed,
paraffin embedded (FFPE) specimens using multiplex immunohistochemistry (mIHC) to assess the immune
microenvironment and cyclic Immunofluorescence (cycIF) to assess the composition and molecular states of
tumor cells and their microenvironments, and (c) paraformaldehyde fixed, resin embedded (PFRE) specimens
using a Focused Ion Beam Scanning Electron Microscope (FIB-SEM) to identify ultrastructural changes in 2D
images and targeted 3D images. Omic characterization of the same tumor samples is provided by the SMMART
Program. A Data Analysis Unit is developing and deploying tools to (a) manage, analyze, and visualize omics
and imaging datasets, (b) integrate omics and imaging datasets through crosswise mapping to create single
timepoint tumor maps and quantify systems biological functions of tumor cellular subpopulations, and (c) explore
differences between pre- and on/post-treatment tumor maps to reveal mechanisms of resistance. The
Administrative Unit facilitates the coordination, operation, interaction, and evaluation of activities within the OMS
Atlas and between OMS Atlas scientists and the HTAN. In this project, we will complete our planned OMS Atlas
project through the following Aims: (1) perform characterization of five additional patient cases using our omics
and multiscale imaging assays; (2) upload our remaining datasets and metadata to the HTAN data coordinating
center; and (3) perform integrated data analysis across our atlas case datasets as well as HTAN trans-network
project datasets to identify tumor changes on therapy and the implications of those changes on breast cancer
treatment. By accomplishing these aims we will complete and fully share our multimodal spatial atlas of 30
metastatic breast cancer cases undergoing treatment.

Public health relevance
PROJECT NARRATIVE Treatments of metastatic breast cancer typically are not durable. The OMS Atlas project will apply state-of-the- art analysis tools to tumor samples taken at multiple times during treatment in order to identify changes in the components and structures of these cancers that enable them to escape therapeutic control. This information will help guide the development of new therapeutic approaches that can be used to reestablish control and develop new diagnostic procedures that will guide the use of these treatments.